Regulation and Function of Stromal Macropinocytosis in Pancreatic Ductal Adenocarcinoma

PROJECT SUMMARY
Recent years have witnessed an appreciation of the role that metabolic adaptation plays in conferring survival
advantages to cells that encounter the harsh nutrient-poor conditions of the tumor microenvironment. Of
particular relevance to this proposal is the now widely accepted notion that macropinocytosis, an endocytic
mechanism of fluid-phase uptake, functions in tumors as an amino acid supply route. By stimulating the uptake
of extracellular protein and targeting it for lysosomal degradation, macropinocytosis provides cells with a
source of protein-derived amino acids, allowing tumors to circumvent amino acid depletion and survive nutrient
stress. Pancreatic ductal adenocarcinoma (PDAC) tumors are deficient in glutamine, a vital nutrient that
supports tumor growth. Our published work in PDAC cells has established that glutamine depletion has the
capacity to modulate macropinocytosis – dialing the process up or down as required. Interestingly, our
preliminary data presented in this proposal demonstrate for the first time that glutamine scarcity can also
stimulate macropinocytosis in cancer-associated fibroblasts (CAFs). Mechanistically, we have attributed
glutamine stress-induced macropinocytic uptake in CAFs to a CAMKK2-AMPK signal that leads to the Rac1-
dependent actin cytoskeleton dynamics that are required for macropinocytosis. AMPK is a bioenergetic stress
sensor that is most often studied in the context of glucose starvation, which unlike glutamine depletion, does
not boost CAF macropinocytosis. Notably, not much is known about AMPK activation and function during
glutamine depletion. Our preliminary studies suggest that macropinocytosis has a dual purpose in CAFs – it
can serve to sustain CAF viability and function, and it can provide secreted amino acids to nourish the tumor
cells. Importantly, our in vivo and in vitro examinations of macropinocytosis in normal fibroblasts, as well as in
CAFs originating from other tumor types, suggest that glutamine depletion-induced stromal uptake is unique to
pancreatic CAFs. Based on these data, our central hypothesis is that glutamine scarcity selectively drives
CAMKK2-AMPK-dependent macropinocytosis in CAFs, and that stromal macropinocytosis is a process that
can be harnessed in PDAC therapy. In this proposal, we will 1) examine the molecular mechanisms driving the
selective role of glutamine in CAF macropinocytosis, 2) functionally characterize stromal macropinocytosis in
PDAC, and 3) determine whether the stromal reorganization that occurs with macropinocytosis inhibition can
be leveraged for PDAC therapy. This project will be of great significance, novelty and impact, as it will
constitute the first evaluation of the role of macropinocytosis in the PDAC tumor stroma and the first analysis to
selectively link glutamine starvation to CAMKK2-AMPK signaling. Moreover, because macropinocytosis is
important in both the tumor cells and the stroma, our work could have tremendous impact on the development
of novel therapeutic modalities for PDAC.

Public health relevance
PROJECT NARRATIVE Pancreatic ductal adenocarcinoma (PDAC) is projected to be the second leading cause of cancer-related deaths in the United States and has been recognized as a recalcitrant cancer that requires accelerated research via the implementation of a long-term strategic plan. PDAC tumors have scarce nutrients, and to bypass this nutrient deficiency, cancer cells use an endocytic process called macropinocytosis as an amino acid supply route. We have identified that tumor support cells, called stromal cells, also use macropinocytosis for their survival and we propose to study how this uptake pathway works in these cells and whether it represents a vulnerability that can be targeted in PDAC therapy.